MAINTENANCE OF LOW-TEMPERATURE SERUM RESPOSITORY

Store at low temperature (-50 to -70 degrees C) serum samples from blood donors, blood recipients, and non-transfused control patients accumulated in the course of studies (performed elsewhere) on post-transfusion hepatitis. The contractor will also alliquot, package, and ship serum to NHLBI-approved recipients.